Targeting complement to enhance antitumor immunity and control malignant effusions in patients with recurrent epithelial ovarian cancer

Abstract
Epithelial ovarian cancer (OC) is the leading cause of death from gynecological malignancies in the United
States. While OC is immunogenic and increased infiltration of cytotoxic T lymphocytes (CTL) correlates with
longer survival, single agent checkpoint inhibitors are largely ineffective in the relapsed/refractory setting. Our
long-term goal is to develop novel approaches to overcome obstacles to durable antitumor immunity to make
immunotherapy more effective. Our results point to previously unrecognized mechanisms for mature
neutrophils acquiring a suppressor phenotype within the tumor microenvironment (TME). Neutrophil
suppressors inhibited stimulated proliferation of circulating naïve, central memory, and effector memory T cells,
and of tumor-associated lymphocytes (TAL) from patients with newly diagnosed OC. Induction of the neutrophil
suppressor phenotype required complement signaling and NADPH oxidase activation. A similar complement-
dependent neutrophil suppressor phenotype was induced by ascites from patients with recurrent OC and from
malignant effusions from patients with a number of metastatic cancers, underscoring the generalizability of our
findings. These results in human samples and work by others in tumor-bearing mice support targeting
complement to enhance anti-tumor immunity. We will evaluate APL-2, a peptide C3 inhibitor, in a randomized
phase 2 clinical trial in patients with recurrent OC and persistent malignant effusions. APL-2 was safe and
superior to eculizumab for paroxysmal nocturnal hemoglobinuria (PNH) and is FDA-approved for this
indication; it’s use in cancer is novel. Following a safety lead-in, patients will be randomized to the following
cohorts: (i) bevacizumab (anti-VEGF); (ii) APL-2 + pembrolizumab (anti-PD1); and (iii) APL-2 + pembrolizumab
+ bevacizumab. Specific Aim 1: To evaluate safety and control of malignant effusions as primary endpoints
and progression-free survival (PFS), objective response rate (ORR), disease control rate (DCR), overall
survival (OS), and quality of life (QoL) as secondary endpoints. Specific Aim 2: To determine the effects of
APL-2-based therapy in modulation of immune responses in the TME. Patient samples (blood, effusion, tumor)
will be collected at baseline and at pre-specified time points during the trial. We will test the extent that APL-2
will abrogate neutrophil suppressor activity and expand activated T cells in the TME. A combination of
functional studies and transcriptional and mass cytometry profiling of circulating and ascites neutrophils and T
cells will be performed. The impact of our proposal is to gain safety and preliminary efficacy data on APL-2-
based regimens in recurrent OC with malignant effusions and a detailed understanding of how these regimens
modulate the immune landscape in the TME. This research is expected to establish the foundation for larger
randomized trials to definitively test the efficacy of C3 inhibition in enhancing cancer immunotherapy.

Public health relevance
Narrative Our results point to mature neutrophils recruited to the tumor microenvironment suppressing the expansion and activation of T cells required for anti-tumor immunity. This suppressor activity was dependent on a number of neutrophil functions, including complement signaling, a therapeutically targetable pathway. The impact of our proposal is to gain safety and preliminary efficacy data on APL-2-based regimens in recurrent epithelial ovarian cancer with malignant effusions and a detailed understanding of how these regimens modulate the immune landscape in the tumor microenvironment.